Center of Biomedical Research Excellence, Epigenomics of Development and Disease

UNIVERSITY OF NORTH DAKOTA
EPIGENOMICS OF DEVELOPMENT AND DISEASE
OVERALL
PROJECT SUMMARY
The goal of this COBRE II application is to expand and enhance research into epigenetic
mechanisms underlying development and disease at the University of North Dakota by
providing ongoing support to the Epigenetics Working Group (EWG). In COBRE I the EWG
made significant progress towards development of an epigenetics/epigenomics program
through support of individual projects; recruitment of epigenetics experts to our group and
supporting faculty development through mentoring programs. We established a comprehensive
Genomics Core to meet the needs of the epigenetics community and provided technical and
financial support that increased the number of researchers in our community utilizing epigenetic
approaches. In Phase I our COBRE Investigators made important discoveries that resulted in
253 papers published in high impact journals, 66 poster and oral presentations by Project
Leaders at invited seminars or scientific meetings, and the awarding of more than $10.8 million
in external funding primarily from R01, R21, and NSF grants.
Here we seek to maintain this momentum through continuation and expansion of these
programs via the following strategies: We will recruit faculty with interests and expertise that
increase the size of our group and extend our competencies into mechanistic and translational
areas; We will enhance the offerings of the Genomics Core to further increase the ability of our
group to perform high-quality research; We will enhance the ability of our investigators to
transition to independent funding through support of individual projects and scientific and faculty
development mentoring programs. Our long-term goal is to transition the EWG into a
sustainable scientific center dedicated to understanding molecular mechanisms of
developmental and pathological disorders that will attract top talent, train the next generation of
scientists, and become a regional hub for cutting edge epigenetics research.
!
!
!

Public health relevance
UNIVERSITY OF NORTH DAKOTA EPIGENOMICS OF DEVELOPMENT AND DISEASE OVERALL PROJECT NARRATIVE The goal of this project is to enable the growth and sustainability of our Center of Biomedical Research Excellence “Epigenomics of Development and Disease” by supporting (1) Research Projects focused on epigenetic mechanisms in development and disease, (2) a Genomics Core providing infrastructure and technology essential to our group and the wider research community, (3) an Administrative core to provide educational, oversight, and faculty development programs. These activities will enhance our ability to perform cutting edge research that relates to public health through identification of mechanisms and potential treatments of human diseases caused by epigenetic processes.